World Health Organization Study Of Health Behavior In Sc

NICHD is evaluating adolescent injury causes, violence, and related behaviors through participation with the World Health Organization Study of Health Behavior in School Children (WHO-HBSC). The study addresses the hypothesis that U.S. youth may have adopted lifestyles that place them at greater risk for certain health problems than their counterparts in other nations. The WHO-HBSC is used to monitor and investigate patterns, determinants and effects of health related behaviors. International comparisons test the degree to which such behavior is a natural and inevitable part of current adolescent development. Analysis of differences and similarities will be conducted to help identify influential factors including family, school and peers. Multiple and different cross-national comparisons are a feature of this study that allows analysis and hypotheses testing of policy differences, cultural differences and natural experiments. The Epidemiology Branch collaborated with the Center for Research on Mothers and Children (NICHD) to perform the first full surveys as required for participation in the WHO collaboration. The WHO coordinates a quadrennial survey that compares health behavior in adolescents in 30 countries. Data from the 1996 preliminary survey have been presented in international conferences and are under analysis. NICHD and other countries completed the full survey in 1998. International comparisons of various health behaviors in 30 countries show that the U.S. ranks 14th in medically attended injuries but in first and second place for injuries occurring in homes and schools respectively. The U.S. students rank higher than most countries in both prevalence and use of medications for headaches, stomach aches, and backaches. Girls report a higher frequency of problems than boys. Data from the HBSC Survey have examined the prevalence of bullying behavior in the U.S. and association with psychosocial adjustment. Thirty percent of students reported involvement with bullying which is associated with poorer psychosicial adjustment than with those not involved. This study highlighted that the issue of bullying merits serious attention for research and prevention. With support from NICHD, HRSA has supported conduct of the HBSC survey in the U.S. along with over thiry other countries during 2001-2002.